A lifecourse approach to evaluating the effect of structural stigma on cancer risk factors among sexual minorities

Project Summary
Sexual minorities have been found to have an increased burden of several cancer risk factors, including
tobacco use, alcohol consumption and obesity. Over the last decade, there has been substantial advancement
in the identification of social and contextual factors related to sexual minority health, and exposure to structural
stigma has been implicated as a potential explanatory factor this disparity. Thus, intervening on factors related
to structural stigma could be a promising approach for reducing the burden of cancer risk factors among this
highly marginalized community. Evidence suggests that effects of exposure to stigma during adolescence
could be different than stigma in later years, and prior studies that have attempted to examine these lifecourse
effects. However, this research has major gaps. First, these studies were not nationally representative.
Second, they did not explicitly use lifecourse methods to evaluate these effects. Thus, our study proposes to
explore the effects of lifecourse exposure to structural stigma on tobacco use, heavy alcohol consumption, and
being overweight or obese using a nationally representative dataset.
The goal of this proposal is to evaluate lifecourse effects of exposure to structural stigma on sexual
minority engagement in cancer risk factors. Using publicly available administrative datasets, we will update
and refine a previously constructed state-level measure of structural stigma that was created in 2011 by
including more granular county-level components that have been demonstrated to be important for the health
of sexual minorities (aim 1). Using data from four waves of the National Longitudinal Study of Adolescent to
Adult Health, we will apply this updated measure to evaluate the effects of life-course exposure to structural
stigma on cancer risk factors among sexual minorities (aim 2). Finally, we will estimate the intersectional
effects of exposure to structural stigma by gender, race/ethnicity, and socioeconomic status (aim 3). The
interdisciplinary training environment for this proposal will provide the applicant an opportunity to enhance
methodological skills, build research competency, and augment content expertise in order to become an expert
in the intersection of cancer prevention and sexual minority health.

Public health relevance
Project Narrative Sexual minorities are burdened by a constellation of factors that put that at greater risk for developing cancer, including tobacco use, heavy consumption of alcohol, and obesity. One potential explanation for the increased burden of these factors is exposure to structural stigma on the basis of sexual identity, yet there is little evidence on potential life-course effects of exposure. This study will use rigorous epidemiologic and biostatistical methods to evaluate the life-course effects of exposure to structural stigma on sexual minority engagement in cancer risk factors.